Physical Biology of the Cellular Glycocalyx

Project Summary/Abstract
All cells in the body are covered with a sugar- and protein-rich material called the glycocalyx. Specific changes
to the composition and organization of the glycocalyx are linked to lethal cancers and other debilitating diseases,
but the mechanisms are not fully understood. Our group’s mission is to uncover the physical principles that define
glycocalyx function with the hope that we can reprogram cells back to normal, healthy states or other desired
phenotypes through rational manipulation of the glycocalyx. An interwoven mission is to develop the
infrastructure—custom-tailored experimental tools and computational models—necessary to propel the early
stages of biophysical inquiry in glycobiology. Our proposal will develop imaging tools intended to resolve the
nanoscale architecture of the glycocalyx and probe its physical properties. We will continue to advance a
systematic approach for engineering the biochemical and biophysical states of the glycocalyx through genetic
methods. Theoretical models will be constructed to understand structure-function relationships for the glycocalyx.
The tools and models that we develop for glycocalyx research will be applied to understand how the glycocalyx
physically regulates various modes of intercellular communication, including through cell-surface receptors,
highly curved membrane structures, and extracellular vesicles. Cell surface receptors reside and operate within
the densely crowded glycocalyx. We will test the specific hypothesis that entropic forces arising from
macromolecular crowding in the glycocalyx can strongly influence receptor assembly and activation. We will
initially consider the effects of glycocalyx crowding on the dynamics and activation of growth factor receptors,
including the epidermal growth factor receptor family. Works from our group have implicated transmembrane
mucins and other membrane-anchored polymers in the glycocalyx as membrane curvature generating machines.
Here, we will investigate how membrane-bending by the glycocalyx can support the projection of microvilli and
the secretion of extracellular vesicles that bud from the plasma membrane and tips of microvilli. We will consider
whether the residual glycocalyx on vesicles controls vesicle stability, fusogenic properties, and communication,
including through the glycan epitopes that the vesicles carry. Our overarching hypothesis is that the biophysical
properties of the glycocalyx play key roles in the transmission and receipt of biological information to and from
cells. Emerging from our hypotheses is a vision that glycocalyx engineering and pharmacological targeting of
the glycocalyx represent viable strategies to harness control over cellular interactions in tissue engineering,
regenerative medicine, and cell-based therapeutics. Insights from our work are intended to inform the
development of therapeutic strategies that can correct the broken channels of intercellular communication that
are ubiquitous in diseases such as cancer.

Public health relevance
Project Narrative The mammalian cell surface is coated in a sugar-rich material called the glycocalyx, where much of life’s sensory machinery resides and operates. The research in our laboratory is focused on developing a physical understanding of the glycocalyx, and how it regulates the exchange of information between cells. Our studies are expected to provide new insight into how intercellular communication is compromised in disease states, such as cancer, and how we might intervene therapeutically to normalize and correct the flow of information amongst the cells of the body.